ZFP36, an RNA Binding Protein that Regulates DNA Repair and Cell Proliferation in PAH

SUMMARY
Pulmonary Arterial Hypertension (PAH) is a pulmonary vascular disease characterized by increased pulmonary
arterial pressure. PAH patients are young, have poor life quality, and have a short life expectancy. This
daunting fact underscores our need for innovative approaches in PAH. PAH arises from a pro-proliferative and
anti-apoptotic phenotype of pulmonary arterial smooth muscle cells (PASMC), endothelial cells (PAEC), and
fibroblast. Recent advances linked this phenotype to a genome-wide deregulation of gene expression.
Therefore, it is imperative to decode the cause of this deregulation to find new therapies. Regulation of gene
expression is governed, in large part, by one main class of protein: RNA-binding proteins (RBP). RBPs
regulate the fate of hundreds of transcripts at once through the recognition of specific motifs that confer them a
high therapeutic potential. However, limited data exist on their implication in PAH. Here, using large-scale
transcriptomic data from PAH patients' lungs, and cultured PASMC and PAEC, we found ZFP36 an RBP
increased in lungs and further enriched in PASMC but not in PAEC. We used computational biology to identify
the targets of ZFP36 and characterize their functions in PAH-PASMC. Our data show that ZFP36 targets are
lead actors in DNA repair and resistance to apoptosis (e.g. RFC3) and cell cycle (e.g. ANAPC4). In-vitro
experiment on PAH-PASMC confirmed the up-regulation of ZFP36 targets and the role of ZFP36 in their up-
regulation, as well as the role of ZFP36 in DNA repair and cell cycle. In addition, we found that inhibition of
ZFP36 in Sugen/Hypoxia rats reduced PH severity.

Public health relevance
PROJECT NARRATIVE Patients suffering from PAH (pulmonary arterial hypertension) are young and have a poor life quality and a short life expectancy despite current treatments. Recent advances showed that PAH arose from a genome-wide deregulation of gene expression. In this proposal, we aim to explore the therapeutic potential of RNA-binding proteins in PAH through the integration of computational and experimental approaches.